Construction and Analysis of Retrovirus Mutants

This proposal describes the genetic analysis of the Gag and Pol proteins of the Moloney murine leukemia virus and of the cellular host proteins with which they interact. We have used the yeast two-hybrid system to identify novel mammalian proteins that bind to various specific domains of the Gag and Pol gene products. We will now focus our ongoing efforts on several of these new targets: the IQGAP proteins, which interact with the MA portion of Gag;two components of the SUMO transferase system, which interact with the CA portion of Gag;and the ribosomal protein S3a, which binds the RNA pseudoknot at the Gag-Pol border. Biochemical methods will be used to confirm and characterize the interactions between the viral and cellular proteins both in vitro and in vivo. To determine the role of these proteins in virus replication, mutations in the viral genes will be identified that specifically abrogate the interaction with the host protein. These mutations will be introduced into the viral genome and the effects on virus replication in cell culture will be determined. Reversion analysis will be used to further define the requirements for the interaction, and to confirm the importance of the interaction for virus replication. Dominant interfering alleles and RNAi methods will be used to document the requirement for the interaction, and to define the stage of the life cycle at which the proteins act. The generality of the results will be tested by examining the effects of the genes on the replication of a panel of retroviruses of other families. These experiments will significantly extend our understanding of retrovirus replication, and may provide important new targets for antiviral intervention. PERFORMANCE StTE(S) (Ot_lanizagon, city, state) Columbia University 70t W. 168th Street New York, NY 10032 KEY PERSONNEL. See instructions, Use con_nuationpages as neededto provide the required information Start with Principal Investigator. List all other key personnel in alphabetical order, last name first. N_a_e Organization Stephen P. Goff Columbia University Andrew Yueh Columbia University Margaret Wang Columbia University Juliana Leung Columbia University Frank Appah Columbia University Anne Burns Columbia University in the format shown below, Role on Project Principal Investigator Postdoctoral Res. Sci. Grad. Res. Asst. Grad. Res. Asst. MD/Ph.D. Grad. Res. Asst. Disclosure Permission Statement_ A_ormable to SBIPJSTTR On;v. See instructions, r-] Yes E] No PHS 398 (Rev, 05/0t) Page 2 Form Page 2 PrincipInavelstigator/Program Director (Last, first, middle): GO_ StcphcE1 ]:). The name of the principal investigator/program director must be provided at the top of each printed page and each continuation page. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page ......................................................................................................................................................... t Description,